Neuronal and vascular interactions in the CNS

Project Summary/abstract:
There is no organ in the body that more heavily depends on a continuous supply of blood than the brain. The
importance of the circulatory system to the brain is demonstrated by the fact that the brain makes up 2% of
total body mass but it receives 20% of cardiac output. Furthermore, the brain does not contain local fuel
reserves, as peripheral organs do. During behavior, brain regions are recruited for specific tasks and must be
brought “online” quickly. The brain regulates its own blood supply via a process called neurovascular coupling,
in which neural activity rapidly increases local blood flow to meet moment-to-moment changes in regional brain
energy demand. Impairments in neurovascular coupling contributes to neurodegeneration and vascular
dementia. Neurovascular coupling is also the basis for functional brain imaging, which is currently the only way
to infer brain-wide neuronal activation in humans. Despite the importance of understanding how the brain
regulates its own blood supply, the molecular and cellular mechanisms underlying neurovascular coupling are
still not clear. In this proposal, we have developed a two-photon in vivo imaging paradigm that can
simultaneously measure neural activity (via a genetically encoded calcium indicator) and vascular dynamics
(vessel diameter and blood flow) at single-vessel resolution in awake mice, enabling us to capture the
neurovascular response to a natural stimulus (whisker stimulation) at high temporal and spatial resolution in
vivo. We will combine this state-of-art in vivo imaging techniques with powerful molecular, electrophysiological,
ultrastructural, and genetic approaches to elucidate the fundamental cellular mechanisms governing
neurovascular coupling. Our preliminary data with in vivo live imaging and mouse genetics in the barrel cortex,
suggest that endothelial cells (ECs) in the brain play active roles in neurovascular coupling. Traditionally, ECs
were considered to be passively involved in neurovascular coupling, and to be a homogenous population. We
found aECs and cECs display molecular and subcellular differences, and play distinct roles during
neurovascular coupling. Our proposed work will identify the cellular, subcellular, and molecular mechanisms
by which endothelial cells from different segments of the vascular tree initiate, transmit, and implement
neurovascular coupling. Specifically, we will demonstrate how different type of ECs along the vascular tree
mediate neurovascular coupling, thus connecting the dots between neural activity and local blood flow change.
We expect that our ability to image CNS small blood vessels non-invasively in awake mice with high spatial
and temporal resolution, along with other sophisticated techniques, will allow us to identify critical molecular
and subcellular mechanisms that underlie neurovascular coupling in vivo. Moreover, our structural and
molecular findings will provide tools that can be broadly used by the field to cerebrovascular biology. Finally,
the data will provide critical information to accelerate our understanding and treatment of CNS diseases related
to small vessels and vascular dementia.

Public health relevance
Project Narrative (public health relevance): Many symptoms of cerebrovascular diseases and nervous system disease are preceded and perpetuated by impaired neurovascular coupling. Understanding and identifying critical molecular mechanisms that underlie neurovascular coupling in vivo will advance the prevention, diagnosis and therapy of diseases and improve the imaging and data interpretation of fMRI in humans. Specifically, the tools and database we generated and knowledge we learned will accelerate our understanding and treatment of cerebrovascular diseases, neurodegenerative diseases, and vascular dementia.